Extracellular Potassium and Astrocytic Kir4.1 Modulate Interneuron Activity in the Cerebral Cortex

PROJECT SUMMARY
This application is for a diversity supplement to the R01 NS127819-01 “EXTRACELLULAR POTASSIUM AND
ASTROCYTIC KIR4.1 MODULATE INTERNEURON ACTIVTY IN THE CEREBRAL CORTEX” of Dr. Moritz
Armbruster at Tufts University. The candidate is Reyna Gariepy, a pre-doctoral student in the lab of Dr.
Armbruster. Reyna will take tools currently in use in the lab and use them to pursue her interests to investigate
how GABA dynamics are shaped by astrocytes. Reyna qualifies as a diversity candidate as a Latina, first
generation college student, and her economically disadvantaged background. Therefore, she is a member of
multiple underrepresented groups. This supplement will fund Reyna for 3 years of her graduate thesis work.
Funding for Y3 will be contingent on submission of an NRSA application during Y2. During this time Reyna will
receive training in cellular neuroscience, glial biology, epilepsy and more. She will gain expertise in
biochemical assays, astrocytes and neuronal electrophysiology, iGABASnFR imaging, and data and statistical
analysis. This training will guide her towards an NRSA application and future as a leader in neuroscience
research. Ms. Gariepy is devoted to academic research with a focus on epileptogenesis. Dr. Armbruster, is a
junior research faculty in the Neuroscience Department at Tufts University who has extensive experience in
astrocyte-neuron interactions and utilizing live-cell imaging approaches. To increase Reyna’s opportunities for
development, we have included Dr. Chris Dulla as a senior mentor. Dr. Dulla has a great track record of
mentorship, including the 2018 Landis Award for Outstanding Mentorship. The project laid out here will give
Ms. Gariepy excellent and rigorous training in GABA neurotransmission, neuron/glial interactions, and cutting-
edge imaging modalities. Dr. Armbruster, and Ms. Gariepy have developed a structured, rigorous, and
customized mentorship and training plan. The funding offered through this supplement will give Reyna a clear
path toward an exciting future as an up and coming researcher in the field of epilepsy and GABA
neurotransmission. The activities laid out and the enrichment opportunities will be critical to Ms. Gariepy’s
development and future as a successful independent investigator.

Public health relevance
PROJECT NARRATIVE. This application is for a diversity supplement to the R01 NS127819-01 “EXTRACELLULAR POTASSIUM AND ASTROCYTIC KIR4.1 MODULATE INTERNEURON ACTIVTY IN THE CEREBRAL CORTEX” of Dr. Moritz Armbruster at Tufts University. The candidate is Reyna Gariepy, a predoctoral student in the lab of Dr. Armbruster.